Providing proprioceptive information through biomimetic multi-electrode stimulation patterns

Project Summary
The overall goal of this project is to provide proprioceptive information to tetraplegic patients
and amputees, thus augmenting current efferent interfaces. Restoring proprioception is vital for
restoring motor control, evidenced by extreme movement impairments in individuals with
proprioceptive loss. Despite this, proprioceptive interfaces have received less attention and have
had less success than tactile interfaces, which can provide contact location information to a spinal
cord injured patient through intracortical microstimulation (ICMS). Developing techniques to
provide proprioceptive information during movement remains a critical and unsolved problem.
Tactile interfaces have found success by mimicking the localized response recorded in
primary somatosensory cortex evoked by punctate stimuli. In contrast, limb movements evoke a
complex spatial pattern of neural activity across area 2 of primary somatosensory cortex (S1). It
may be that recreating this spatial pattern of activity will elicit naturalistic sensations of limb
movement. I propose to use multi-electrode ICMS (mICMS) to do this. I expect this biomimetic
approach to provide conscious and subconscious proprioceptive information, both of which are
vital for restoring motor control.
The effect of this biomimetic approach will be compared to nonbiomimetic approaches in two
Specific Aims. In Aim 1, I will compare the efficacy of these stimulation approaches for providing
conscious perception of limb movements, which will reduce phantom limb pain and improve
prosthesis satisfaction. Here, monkeys will report the direction of perceived hand movement by
reaching in that same direction. I will test these stimulation approaches in naturalistic cases and
after monkeys learn mappings between mICMS and reach direction. In Aim 2, I will evaluate
whether mICMS can provide the feedback required to update an ongoing reach, a critical
component of proprioception for which visual feedback is insufficient. While reaching, either a
mechanical or virtual perturbation delivered through a brief train of mICMS will be applied to the
monkey. During mechanical perturbation trials, monkeys will need to correct their reach to hit the
target. On mICMS trials, I expect monkeys to correct their reach as if their hand were physically
moved. These two aims provide a complimentary approach to restoring proprioception, as both
conscious perception of limb movements and rapid feedback required to update reaches are vital
components of proprioception.

Public health relevance
Project Narrative Restoring proprioception, our sense of body movement and postures, is vital for restoring motor control in tetraplegic patients and amputees, as movements without proprioceptive feedback are slow and inaccurate. This project aims to develop methods which provide both conscious perception of limb movements and proprioceptive feedback required to update ongoing reaches, either by eliciting naturalistic sensations or through learning. In the long term, these methods will further our knowledge of how to provide proprioceptive information, which will improve prosthesis embodiment and motor control.